Societal stressors, adaptive factors, and developmental timing: Influences on Latinx mental health from early childhood through young adulthood

Abstract
In 2021, the US Surgeon General issued an advisory warning of a youth mental health crisis, exacerbated
by the COVID-19 pandemic. Latinx youth, a group marginalized by race, ethnicity, class, and culture, have
exceedingly high rates of internalizing symptoms such as depression and anxiety. Ecosocial theory posits that
historical, societal, and ecological conditions over the life course have critical impacts on later mental health.
This research will examine how distal and proximal societal stressors influence mental health trajectories for a
diverse sample of US Latinx youth followed from early childhood into young adulthood. Distal societal
stressors, such as the pandemic, anti-immigrant rhetoric, and neighborhood ethnic marginalization, may
increase Latinx youth’s internalizing symptoms directly and indirectly through proximal societal stressors, such
as families’ COVID-related economic, health, and social problems and individuals’ perceptions of immigrant
threats and ethnic discrimination. These kinds of societal stressors also may have direct and indirect effects on
increased internalizing symptoms through family stress processes, including maternal depression and harsh
parenting. The nature of youth’s exposure to these stressors (for how long, when in history and development)
and the presence of protective adaptive factors (e.g., parents’ cultural socialization; youth self-regulation) can
moderate stressor impacts on internalizing symptoms. This research will leverage advances in Integrated Data
Analysis (IDA) to pool data from five longitudinal Latinx cohort studies to obtain a single, aggregated data set
with 2,515 Latinx mother-youth dyads following youth from age 2 to 22 (2010-26). IDA increases statistical
power, sample heterogeneity and generalizability, and measurement breadth and depth in ways not possible
with a single data set. The application will support 1) collecting cross-sectional data for 500 Latinx individuals
to establish standard measurement scaling across the five studies; 2) integrating data across all five studies;
and 3) extracting data from Twitter and the US Census to assess anti-immigrant rhetoric and neighborhood
factors, respectively. Analyses will utilize a general latent variable modeling framework that includes multilevel
modeling, structural equation modeling, item response modeling, and finite mixture modeling. We hypothesize
a cascade of effects from distal societal stressors to increased internalizing symptoms through greater
proximal societal stressors and increased family stress processes. We expect that pathways linking societal
stressors to youth’s internalizing symptoms will vary depending upon the presence of adaptive factors, the
developmental timing and cumulative effects of youth experiences, and sociodemographic characteristics (e.g.,
youth biological sex, family national origin). This study offers an unparalleled opportunity to understand Latinx
mental health in relationship to multi-level stressors, adaptive factors, and sensitive periods of development. As
Latinx youth comprise more than one-in-four US youth, findings from this research will help guide new
preventive interventions and refine existing ones for a large and growing segment of the US population.

Public health relevance
PROJECT NARRATIVE This research will explain how societal stressors experienced from early childhood into young adulthood affect Latinx youth’s mental health. Using an integrated data analysis approach, investigators will pool data from five longitudinal Latinx cohort studies spanning 2010-2026 to follow 2,515 Latinx youth and mothers from youth’s age 2 to 22. Knowledge about Latinx youth’s mental health trajectories within a context of societal stressors and modifiable family stress processes and adaptive factors will inform effective Latinx mental health interventions.